Signal sensing, hyphal development and pathognesis of Candida albicans

The original Project Summary/Abstract document has not changed as a result of the proposed supplement activities.

Public health relevance
The original Project Narrative document has not changed as a result of the proposed supplement activities.